Adult Changes in Thought (ACT) Research Program Core C: Life Course Core

CORE C: LIFE COURSE CORE
PROJECT SUMMARY
The Adult Changes in Thought (ACT) U19 Research Program’s overarching goal is to use a life course
approach to investigate modifiable and other factors that influence cognition and Alzheimer’s disease and
related dementia, including better understanding of underlying mechanisms. The Life Course Core provides
data and theoretical support for this goal. The Core leverages existing Kaiser Permanente Washington
(KPWA) electronic data files and medical records, existing ACT data, new survey instruments, and data in the
public domain. By efficiently building on the extensive resources of ACT as a long-standing longitudinal cohort
set in a health care delivery system, the Life Course Core will support scientific inquiry to enhance our
understanding of aging, especially brain aging and dementia and Alzheimer’s disease. The interdisciplinary
Core team with expertise in life course epidemiology, the built environment, neuroscience, and health policy
and econometrics will support the life course framework in all Projects and Core activities. The Life Course
Core’s Specific Aims are: Aim 1) To aggregate data from disparate sources (including administration of a
questionnaire and linkage to external data sources) to characterize socioeconomic status over the life course;
Aim 2) To test the hypothesis that specific crucial times in brain development and function determine the timing
of the relevance of individual and area level socioeconomic status indicators to cognitive trajectories in late life;
and Aim 3) To assist the Projects in identifying relevant life course parameters from newly collected and
existing variables and partner with Cores to integrate the most influential variables into their analyses to
understand the spectrum of robust cognitive function to dementia. Integrating new social and health data over
the life course will allow this Core to work with other cores to support aims across the three Projects and
broader scientific endeavors. We will work particularly closely with the Clinical Core and the Data and
Analysis Core to collect and share data, respectively. The Life Course Core serves a central role in the U19
by providing thematic unification that will transform the future value of ACT U19 Program science.